Infectious Disease/Immunology Stimulating Access to Research in Residency (ID/IMM StARR) Program at Washington University

Abstract
Due to their clinical and research training and expertise, physician-scientists are poised to provide new unique
insights into disease, ultimately leading to advances in treatments. However, there has been a long-recognized
shortage of physician-investigators. While combined MD-PhD programs have helped address this shortage,
there are substantially more physicians without PhD degrees graduating from medical schools who form a
substantial pool of potential investigators to overcome this shortage. Physician-scientists are especially needed
to explore infectious diseases and immune-related diseases to derive new therapeutic advances. Here, the
applicant and his team propose to meet this challenge by focusing on non-PhD physicians with a new R38
Stimulating Access to Research in Residency (StARR) Program in Infectious Disease and Immunology
research (ID/IMM StARR) at Washington University School of Medicine (WUSM). The ID/IMM StARR Program
is designed to provide protected time for mentored research, didactic training, and career development that will
allow residents to fulfill board requirements and take advantage of the robust environment at WUSM for
physician-scientist training and in ID/IMM research. The Specific Aims are to:
Aim 1: Provide Dermatology, Medicine, Neurology, Pathology and Pediatric residents high quality, competency
based, rigorous training in basic or clinical/translational ID/IMM research
Aim 2: Provide 1-2 years of mentored research training, didactic training and other scientific enrichment
activities, and Individual Development Plans for career development to ensure the success of residents
in the StARR Program through close interaction with outstanding scientific mentors, career advisory
committees and program directors
Aim 3: Expand the number and diversity of well-trained residents ultimately performing research, and pursuing
subspecialty fellowships to become independent research faculty in infectious disease and immunology
Aim 4: Perform robust evaluation and tracking to demonstrate the impact of the StARR Program
Thus, R38 residents will be well-prepared for an ultimate career as independent investigators in ID/IMM
research.

Public health relevance
Project Narrative This proposed training program is designed to provide intensive mentored research training for physicians who are in clinical residencies in Dermatology, Medicine, Neurology, Pathology, and Pediatrics, along with exposure to didactic and scientific enrichment activities, and career development. Residents will be able to fulfill their requirements for specialty board eligibility.